Development of Sensitive and Specific Proteomic Biomarkers of Aging, Health, Frailty, and Morbidity in Human Cohorts

Our early work in the first year of this research collaboration with Drs. Luigi Ferrucci and Toshiko Tanaka has demonstrated that biological age, frailty, and mortality can be predicted simply by measuring a panel of proteins in the blood from the Baltimore Longitudinal Study of Aging and InCHIANTI aging cohorts. These results, published in Elife and PLOS Biology, demonstrated that proteins in the plasma are representative of basic aging processes such as cellular senescence, and that a subset of senescence-associated protein biomarkers are predictive of mortality and co-morbidities. The purpose and scope of this research project going forward is to develop and apply state-of-the-art mass spectrometry based proteomic techniques to discover and validate subsets of proteins and protein forms that are representative of aging and disease burdens in human tissues, blood, and other biofluids.